NYCenter for Minority Health, Equity and Social Justice

OVERALL-ABSTRACT
The overall goal of the new RCMI at the City College of New York (CCNY) is to create an integrated multi-tiered
center, the NYCenter for Minority Health, Equity, and Social Justice (NYC-MHESJ). This proposal is founded on
the historic commitment of CUNY MED and CCNY to the Harlem community. Located in Harlem and led by the
CUNY MED, the new RCMI collaborates with CCNY’s Division of Science, the Colin Powell School for Civic &
Global Leadership, and the Grove School of Engineering. It spans basic biomedical, behavioral, social science,
and clinical research. It further develops and strengthens research infrastructure, improves the quality of science,
and enhances the preparation and capacity of early-stage investigators (ESI) to conduct state-of-the-art health
disparities research while, creating strategic communications, and implementing a dissemination plan focused
on underserved NYC communities where deep disparities exist and persist.
The specific aims and key activities for the Overall Core are to:
Aim-1 Support three outstanding R01-level research projects centered on health disparities:
• A basic science proposal focused on end-stage kidney disease, which predominantly affects minority
populations such as African-Americans and Latino(s);
• A behavioral Science project focused on mental health and stigma in adolescents
• A clinical project focused on understanding clinical trial participation and recruitment parameters of
Hispanics with Parkinson’s Disease
Aim-2 Create a Research Capacity Core (RCC) to strengthen CUNY MED and CCNY’s research capacity by
expanding access and training in molecular biology/genomics technologies, access to a biostatistics,
epidemiology, and research design core, Artificial Intelligence (AI), and data and computational science to study
health disparities.
Aim-3 Create and administer an Investigator Development Core (IDC) led by experienced mentors to
develop faculty, award pilot projects, and enhance training activities for underrepresented ESI and faculty within
an effective integrated mentoring program.
Aim-4 Create a Community Engagement Core (CEC) focused on minority health and health disparites
(HD) in underserved NYC communities.
Aim-5 Create a Recruitment Core (RC) to increase the critical mass of senior-level health disparities
investigators.
Aim-6 Develop an Administrative Core (AC) that integrates and aligns institutional and Center goals and
evaluates and supports the Center’s scientific advancement.

Public health relevance
PROJECT NARRATIVE The practical translation of new knowledge, mechanisms, and techniques generated by advances in basic biomedical science research into new approaches for preventing, diagnosing, and treating diseases is essential to addressing health disparities of our diverse community. At the NYCenter for Minority Health Equity and Social Justice, we intend to continuously seek community input at all stages of research, adding an additional dimension to the traditional bench -> bedside paradigm, and in doing so, create a national model to solve health disparities.